JACKSON HEART STUDY (JHS) GRADUATE TRAINING AND EDUCATION CENTER (GTEC) - SHEILA MALONE DIVERSITY SUPPLEMENT

The Jackson Heart Study (JHS), the largest investigation of CVD undertaken in an African-American population, is a single-site prospective epidemiologic investigation in the Jackson, Mississippi metropolitan area of Hinds, Madison, and Rankin counties. The JHS is sponsored by the National Heart, Lung, and Blood Institute (NHLBI) and the National Institute of Minority Health and Health Disparities (NIMHD) at the National Institutes of Health (NIH). The JHS started as a partnership between three local institutions: Jackson State University, Tougaloo College, and the University of Mississippi Medical Center and recruited 5,306 African-American men and women between the ages of 35 and 84. Family members were included in order to permit studies of familial and genetic contributions to CVD. The initial examination phase of the study lasted from the fall of 2000 to March 2004 and involved an extensive examination that included a series of questionnaires (dealing with lifestyle habits, medical history, medications, social and cultural factors), physical assessments (height, weight, body size, blood pressure, electrocardiogram, ultrasound measurements of the heart and arteries in the neck, and lung function) and laboratory measurements (cholesterol and other lipids, glucose, indicators related to clotting of the blood, among others). The information collected in this study includes both conventional risk factors and new or emerging factors that may be related to CVD. It also included newer areas of focus comprising early indicators of disease, genetics, socio-cultural influences, such as socioeconomic status and discrimination, and physiological relations between common disorders such as high blood pressure, obesity and diabetes and their influence on CVD. Exam 2 was conducted between 2005 and 2008, and Exam 3 from 2009 to 2012. The next phase of the JHS extended from 2013-2018 and did not include a clinic exam. The five major aims of the JHS are: (1) Support dedicated time for JHS investigators to conduct data analysis and prepare manuscripts using the wealth of collected JHS data; (2) Facilitate access to study resources and expertise in order to: (a) engage researchers beyond the JHS in collaborative analysis of existing data to produce high quality publications; (b) serve as a training ground for undergraduate and graduate students and early career investigators, as appropriate, to help ameliorate the shortage of minority biomedical researchers; and (c) serve as a platform for ancillary studies; (3) Conduct annual interviews with participants to identify interim hospitalizations and outpatient visits, convey information about the JHS, and serve as a vehicle to recruit for ancillary studies; (4) Continue clinical events identification, investigation, and validation to improve statistical power for risk prediction and hypothesis testing; (5) Perform community health education activities to disseminate health promotion and prevention messages in the Jackson community. The JHS Graduate Training and Education Center (GTEC) has four objectives that will serve to help the JHS achieve all of its aims in general and, in particular, Aim 2b listed above. The four objectives of the GTEC are to: (1) strengthen the base of participating students' knowledge of science and mathematics; (2) provide innovative programs, research opportunities, and mentorship to stimulate and nurture students' interest in science and research; (3) produce publications and informational articles on educational topics for broader audiences; and (4) encourage students to pursue further training for future biomedical careers.